Evaluating indirect survey question methods on reproductive health behavior

Project Summary: "Evaluating indirect survey question methods on reproductive
health behavior"
Abortion is a major component of reproductive health and autonomy, but is increasingly subject
to access restrictions that may dramatically reduce utilization. Beyond general aggregate
statistics, little is known about the characteristics, attitudes, and behaviors of those obtaining
abortions at the state and national levels. A lack of validity of direct survey questions is a critical
barrier to understanding attitudes and characteristics of abortion patients. Indirect survey
question methods have the potential to overcome this barrier. The indirect methods known as
the Item Count Technique (ICT) and the Item Sum Technique (IST) estimate respectively
whether and how many abortions a woman has experienced. In this study, we evaluate the ICT
and IST methods using data from nine states with more and less restrictive abortion policies, in
periods when abortion was more and less restricted. The nine states are located in the Mid-
Atlantic, Midwestern, Southwestern, and Southeastern regions of the US. The study aims are to:
1) Evaluate ICT and IST internal validity assumptions; 2) Evaluate bias of the estimators from
ICT and IST against external abortion statistics from CDC reports and the Guttmacher
Institute’s periodic census of abortion providers by state and by age and race/ethnicity; 3)
Evaluate the performance of different implementations of multivariate regression estimation of
abortion on socio-demographic characteristics and assess sampling-variance gains to
incorporating external abortion count data in combined survey and population data estimators;
and 4) Estimate differences in incidence and mean numbers of abortions by state policy and by
respondent characteristics not readily available in administrative records and provider surveys.
Methodologically, our study will contribute to existing literature by evaluating ICT method for
abortion to a broad social-geographic range U.S. states, by evaluating for the first time anywhere
the validity of the IST method applied to numbers of abortions, and by evaluating the validity of
the ICT and IST methods over a limited period, specifically five years. Substantively, we will
contribute to understanding characteristics, attitudes, and behaviors of those seeking and
obtaining abortions across nine U.S. states both before and after the major state policy changes
of 2022.

Public health relevance
Project Narrative This study evaluates two promising indirect survey question techniques to estimate sensitive reproductive health behaviors and outcomes experienced over a lifetime and over a defined period such as the most recent five years. The knowledge gained will enable development and application of indirect survey questions on sensitive reproductive health topics, and potentially also on other sensitive topics, in future state and national sample surveys.